Testing the efficacy of a CBT-enhanced text message intervention to reduce symptom burden in individuals with post-traumatic stress disorder symptoms and co-occurring hazardous drinking

PROJECT SUMMARY
Posttraumatic stress disorder (PTSD) and hazardous drinking (HD: heavy alcohol use and negative alcohol-
related consequences) commonly develop and co-occur following trauma exposure. The individual and public
health burden of PTSD and co-occurring HD is substantial. Although there are evidence-based behavioral
treatments for co-occurring PTSD and HD, they have limitations that result in many individuals not accessing
these treatments and limited intervention reach – i.e., existing interventions tend to be complicated,
burdensome, and require contact with an in-person therapist. Thus, there is a need to develop additional, novel
interventions that use evidenced-based strategies and that have greater portability and reach. There is a
nascent, scant literature evaluating such types of interventions for veterans, and we know of none aimed at the
general public. The current application, therefore, seeks to refine and test a brief, self-directed, intervention for
individuals from the general public with PTSD and co-occurring HD that can be delivered via text-messaging.
The proposed intervention draws on evidence-based strategies from cognitive behavioral therapy (CBT) for
treating PTSD and co-occurring HD, and it yielded promising findings in a recent pilot study conducted by the
research team. This application seeks to refine the intervention further by testing whether theoretically-driven,
evidence-based strategies from basic cognitive psychology (message framing) and social psychology
(facilitating growth mindsets) result in better outcomes for PTSD symptoms and HD by addressing pilot
participant feedback related to avoidance and motivation. We will identify the most efficacious intervention and
test it in a fully-powered RCT. Thus, Study 1, which will recruit an adult community sample (N = 500), will test
the efficacy of enhancing the CBT text message intervention with message framing (protect against loss vs.
imagine future gains vs. no framing) and mindsets (provide growth mindset message for using skills vs. simple
reminder to use skills) via a fully-crossed 3x2 factorial design. Study 2 will build on Study 1, by conducting a
fully powered (N = 333) randomized controlled trial (RCT) that will test the comparative and long-term efficacy
of the most efficacious CBT-based text message intervention from Study 1 versus an assessment only control
in a community sample of adults with co-occurring HD and PTSD. This proposal is innovative in its approach to
adding to the menu of treatment options for co-occurring PTSD and HD and with its evaluation of the utility of
integrating basic social and cognitive psychology strategies with those from CBT. If successful, it will result in
an efficacious, novel, theory-driven, low burden behavioral intervention co-occurring PTSD and HD that is
readily scalable. Such an intervention could be implemented as a stand-alone intervention or be integrated into
stepped-care approaches, including following mass trauma exposure (natural disasters, mass casualty events,
pandemics) and thus, has the potential for a substantial impact on public health.

Public health relevance
PROJECT NARRATIVE The co-occurrence of posttraumatic stress disorder (PTSD) and hazardous drinking (HD) can be particularly devastating; though evidence-based treatments exist, many individuals with this co-occurrence drop out from or do not or cannot access specialty care. Text-messaging is a mode of intervention delivery that is low-cost, low-burden, and accessible to most people; development and testing of self-directed text message interventions that use evidence- and theoretically-based strategies to reduce PTSD and HD symptom burden is highly needed. Such interventions have the potential for great clinical significance via providing additional, novel treatment options that are readily scalable and have wide reach and thus can have a large impact on individual and public health.